Defining the Effector T cell KLF2 Transcriptome

PROJECT SUMMARY/ABSTRACT
Transcriptional programs which control the activation, differentiation and migration of T and B lymphocytes
have been studied for decades, yet remain incompletely understood. “Master” transcription factors which
drive the differentiation of different classes of CD4 helper cells and CD8 effector cells have been well
characterized, but functions of other transcription factors which regulate the outcome of an immune response
are less well defined. KLF2, a member of the Kruppel-like factor family, has diverse roles in the immune
system, and in particular plays a critical role in controlling migration of T (and B) cells via its control of
expression of key homing receptors which determine selective trafficking capabilities. Other functions of
KLF2 remain mostly undefined. A striking and unusual feature of KLF2 is its rapid loss of expression in T, B
and multiple other cell types following cellular activation. Despite this feature of KLF2 being known for almost
two decades, the physiologic importance of this loss of KLF2 remains poorly defined, despite efforts by
several investigators. We have generated a novel, powerful, and sophisticated mouse model which for the
first time makes possible interrogation of the functions of KLF2 downregulation. In this model, loss of KLF2
expression is completely and permanently blocked in any cell type which expresses or which once expressed
cre recombinase. We present extensive data showing that this novel mouse model has a normal peripheral T
cell compartment prior to immunologic challenge, yet induction of both CD4 and CD8 T cell effectors in
response to infection with LCMV is sharply impaired. Using this powerful and novel mouse model, we
propose to identify the transcriptional and epigenetic basis underlying defects in the generation of effector T
cells associated with failure to turn off KLF2 expression. In Aim 1, we will identify aspects of T cell effector
development which require loss of KLF2 expression, focusing on possible defects in defective or
dysregulated activation, proliferation, or survival, and alterations in cellular metabolism or traffic. In Aim 2, we
will use RNAseq and ATACseq to identify how the transcriptome and regulome of effector CD4 and CD8 T
cells changes as a result of failure to extinguish KLF2 expression. These studies will greatly advance our
understanding of how KLF2 controls the T cell arm of the adaptive immune response.

Public health relevance
PROJECT NARRATIVE Inflammatory diseases are often caused by a class of white blood cell termed T cells. How the various types of mature T cells function and respond to infectious pathogens is incompletely understood. This application focuses on how expression of genes which underlie the ability of T cells to carry out an essential type of immune response called a type 1 response are controlled by the activity of a particular transcription factor called KLF2, which controls numerous aspects of the development, function, and migration of T cells responding to a broad range of infectious agents.